Core C: Human Tissue Validation

PROJECT SUMMARY (CORE C: HUMAN TISSUE VALIDATION)
The Human Tissue Validation Core will provide vital research support to the CWOW. Neurodegenerative disease
pathology and genetics have become increasingly exciting and complex in recent years, with major advances
arising from work accomplished using human postmortem tissue. In this application, Dr. Lea T. Grinberg will lead
the Human Tissue Validation Core (Core C). The Human Core goals are to (1) directly supporting this CWOW’s
Projects with well-characterized and carefully treated human tissue from tauopathy patients and controls; (2)
validating the relevance results from Projects 1 and 2 in human specimens and assembloids; (3) developing
enhanced tools for boosting the amount of information retrieved for each single biospecimen samples.